CORE--ANIMAL FACILITY

The Animal Resources Core (Core B) will provide young adult male and female rats of defined endocrine status after castration and sex steroid replacements. Depending on the study, castrated female rats will receive estradiol, Premarin, or constituents of Premarin (equilin). Aging male and female rats will be maintained for observation after receipt from the supplier. Necropsy records will be maintained on gross organ pathology, e.g. pituitary tumors, to evaluate individual differences in brain responses. Assays will be provided for rat plasma LH, estradiol, testosterone, and corticosterone. Transgenic mice (Project 1) will be bred to establish lines with GFAP promoter constructs engineered for altered responses to estradiol; these mice will also be used in Projects 2 and 4. Tissues will be distributed from hormone characterized rats and transgenic mice to the present projects, as well as to other USC colleagues who are studying estrogen effects on non-neural target tissues.